Joint Cardiovascular Research Lab Alteration and Renovation

Project Title: Nebraska Center for Heart and Vascular Research
Project Summary: Alteration and Renovation Project
The goal of this alteration and renovation project is to update the Joint Cardiovascular Research Lab (JCRL)
by adding a C-arm X-ray imaging scanner intensifier to the chronic procedure surgery suite. The JCRL is a
long-standing existing core and adding this equipment will improve our heart and vascular surgery capabilities.
There is one aim for this alteration and renovation project: to update the JCRL to support large animal heart
and vascular research. The completion of this renovation project will provide extended capabilities to the
current infrastructure of the JCRL by strategically expanding capacity in the JCRL space specifically designed
and equipped for heart and vascular research.

Public health relevance
PROJECT NARRATIVE: ALTERATION AND RENOVATION PROJECT Not applicable